An Investigation of Tandem Repeat Variation in Schizophrenia

PROJECT SUMMARY
Tandem repeats are a prevalent class of genomic variant, prone to high frequency of mutation and known to
underlay some neurological disorders, including the trinucleotide repeat disorders, Huntington’s Disease and
spinocerebellar ataxias. To date, a systematic investigation of the role of TRs in schizophrenia has not yet been
conducted, partly owing to technical limitations in genotyping tandem repeats, as well as lack of access to large-
scale, sequenced schizophrenia cohorts.
The goal of the current project is to apply recently developed TR profiling tools to whole genome sequenced
(WGS), schizophrenia cohorts to identify variation in short tandem repeats (STRs) and variable number tandem
repeats (VNTRs), that may contribute to schizophrenia genetic risk.
The proposed systematic study of TR variation in schizophrenia has a high likelihood of uncovering novel genetic
risk factors. The study will leverage innovative algorithms for high-throughput TR genotyping applied to large
and well-powered schizophrenia cohorts. Therefore, this timely and well-powered approach could lead to novel
insights into the role of tandem repeat variation in schizophrenia and human disease, with important translational
implications.

Public health relevance
PROJECT NARRATIVE Schizophrenia is a neuropsychiatric disorder that affects approximately 1% of the population worldwide, with a significant global public health burden; it can exact a devastating toll on patients who suffer from the illness, their families and loved ones. Through the use of cutting-edge genomics tools and resources, the current project will investigate a specific class of variant, "tandem repeat variation", that may increase schizophrenia risk. The project may thereby elucidate an aspect of the biology of schizophrenia, novel genetic risk factors, with consequent translational implications, paving the path for improved schizophrenia diagnosis and treatment strategies.